The impact and reversibility of obesity-induced molecular and functional alterations to the human endometrium

Almost 42% of US adults are affected by obesity with women at higher risk for severe obesity than men (11.5
vs 6.9%). Obesity has a significant and complex impact on reproduction and is associated with menstrual
irregularities, anovulation, miscarriage, and infertility. While there are several known causes of infertility, most
require invasive and expensive procedures to achieve pregnancy, and, unlike obesity, very few are modifiable.
Obesity impacts all levels of the reproductive axis including the hypothalamus, pituitary, ovary, and
endometrium. While the effects of obesity on the endometrium are poorly defined or understood as compared
to other tissues, both human primary cells and mouse models suggest that obesity has direct effects on the
endometrium, primarily through disrupting endometrial cell decidualization. The current understanding of the
relationship between obesity, endometrial function, and infertility is hindered by several important factors: 1)
Utilization of heterogenous patient populations with obesity-associated reproductive and metabolic conditions
known to impact the endometrium, such as PCOS, 2) reliance on BMI as the only measure of obesity, which
fails to capture the complexity of the disease 3) utilization of insensitive or bulk molecular assessments of the
endometrium which may not capture subtle or localized changes, 4) lack of understanding of how weight loss
effects endometrial health and function. The overall objective of this proposal is to assess the impact of obesity
on the proteomic, transcriptional, and cellular landscape of luteal-phase endometrium and to assess the
reversibility and stability of these changes with significant weight loss achieved via bariatric surgery. The
conceptual innovation of the proposed work is the inclusion of a cohort of extensively-phenotyped women
allowing for disentanglement of commonly co-occurring endocrine and metabolic disorders that have
confounded prior studies, and the assessment of endometrium at multiple timepoints post-bariatric surgery,
thus capturing temporal alterations during and after significant weight loss. The technical innovation is the use
of high-resolution proteomic and cutting-edge single-cell genomic techniques combined with established
functional reproductive assays allowing for assessment of the isolated impact of obesity at a cellular level. We
hypothesize that obesity induces alterations to endometrial cellular subpopulations with resultant variation in
transcription and proteomic profiles that is partially reversible with significant weight loss even when a “normal”
BMI is not achieved. We further hypothesize that measurements of obesity beyond BMI (adiposity distribution
and adipokine levels) will correlate more accurately with cellular alterations and endometrial dysfunction. To
test this hypothesis, in aim 1 we will characterize the molecular (proteomic, single cell-transcriptomic) and
functional (decidualization/senescence) impact of obesity in a cohort of comprehensively phenotyped women
with and without obesity. In aim 2, we will assess for reversibility and stability of these molecular and functional
alterations in women who achieve significant weight loss following bariatric surgery.

Public health relevance
This proposal will examine the impact of obesity and excess adiposity on the human endometrium and will also assess for reversibility of these alterations with significant weight loss achieved via bariatric surgery. We will perform high-resolution mass-spectrometry, single cell RNA-sequencing, and functional assays of endometrial decidualization to better understand how obesity alters the endometrium. Results from this study will provide insight into the pathways by which obesity affects the endometrium and whether or not molecular and functional alterations are reversible with significant weight loss, thus informing improvements in individualized risk assessment, screening, and patient counseling.